Thermodynamically Calibrated RNA Simulations to Decode Mechanisms of RNAMolecular Recognition

This MIRA proposal details a research program that centers around the development
and application of improved, thermodynamically accurate computer models for simulating RNA
3D structures at atomic resolution. These models differ from existing models for RNA in that
they are calibrated to reproduce solution thermodynamic data on the physical behavior of
nucleotides and nucleosides, an approach that is readily extended to include the effects of
unnatural RNAs and RNA-ligand interactions. This technology is particularly important as many
biomedically important RNAs are not amenable to traditional structural biology techniques,
which makes it difficult to establish basic structure-function relationships that must be
understood before potential therapeutic interventions could be designed.
Often, the only available structural information on an RNA of interest are secondary
structure estimates from bioinformatics or from SHAPE chemical probing experiments. This
proposal builds on recent successes in using molecular simulations restrained by sparse
SHAPE or NMR data to simulate the folding pathway of a co-transcriptionally folded RNA, as
well as describe how the flexibility of microRNA/mRNA complexes affect how they bind the
hAGO2 protein. Building on these recent results, a comprehensive research program is
proposed in three major parts. The first is the use of alchemical free-energy calculations to
measure the energetics of RNA base-pairing and recalibrate them against experiment. The
second is a two-dimensional replica-exchange method for fully automated, adaptive RNA
folding incorporating variable strength secondary structure constraints – a method that show
promising results that we expect to scale to large (50-100 nt) RNAs including tertiary motifs.
Lastly, we propose a novel multi-dimensional technique to simultaneously fold RNA aptamers
while also binding small-molecule ligands using Hamiltonian replica-exchange combined with
alchemical free energy calculations – which will be necessary to capture the “induced fit” of the
RNA aptamer upon ligand binding. These calculations will be used to predict ligand binding
modes and engineer optimal RNA biosensors through targeting incorporation of chemically
modified nucleic acids.

Public health relevance
This project proposes a new method for using computer simulations to determine the structure and function of RNA in 3D, atomic detail, for which no experimental structures are available. If successful, these studies will enable the rational engineering and design of RNA-based biosensing/nanotechnology applications as well as help solve challenging puzzles in RNA structural biology to understand how RNA molecules are able to recognize a diverse array of biological targets.